Development and Testing of imHere4U: A Digital Suicide Prevention Intervention for Cyberbullied Adolescents - Supplement

PROJECT SUMMARY/ABSTRACT
The purpose of this administrative supplement is to support Dr. Biernesser’s transition from a mentored career
development K23 award to research independence in the midst of her critical life event. This supplement
support will help ensure continuity of Dr. Biernesser’s research during this important juncture in her career by
providing funds to support her research staff. Together with funds from the parent award, this additional staff
support will allow for increased effort toward recruitment, data collection, and data management that is needed
following her planned time off and amidst increasing caregiver responsibilities. This extra support is especially
important for Dr. Biernesser’s project, which involves a clinical trial that requires critical support from key staff
members to move forward. This supplement support would come during a sensitive time in Dr. Biernesser’s
career and thus would have a meaningful influence on her retention in biomedical research and transition to full
research independence. Indeed, she will be prepared to submit her first applications for independent research
funding (e.g., R01) during the supplement period. Dr. Biernesser will benefit from the additional support to
achieve the needed sample for the study and prepare the data for forthcoming manuscript submissions,
essential steps for successful future grant submissions and the transition to an independent research career.

Public health relevance
PROJECT NARRATIVE This is an application for an administrative supplement to promote research continuity and retention of a NIH mentored career development (K) award recipient. Dr. Biernesser is the PI of a NIMH-funded K23 award who has experienced a critical life event within this past year. Supplement support will help Dr. Biernesser transition to full independence and stay in a biomedical research career by providing funds for added staffing to support recruitment and preparation of study data for final analyses. This staffing will help Dr. Biernesser focus effort on completion of the study’s research and training goals and production of a high-impact manuscripts reporting the study’s findings. There will be no changes to the aims, design, and methods of the current project.